Dosimetry and health effects of internal radionuclides

Dosimetry and health effects of internal radionuclides
We propose to organize a one-day conference “Dosimetry and health effects of internal radionuclides” as a
satellite meeting for the 17th International Congress for Radiation Research (ICRR) that will be held between
August 27 - 30, 2023 in Montréal, Québec, Canada. Considering the appeal of this international meeting, we
believe that we will be able to attract both high caliber speakers and scholars in training just entering the field to
our satellite conference more easily. The conference will be broad in scope – exploring topics covering the
processes leading to possible internal emitter contamination, fate of different radioactive emitters in different
forms after they enter in the body, biological and medical effects of such exposures and possible mitigator
strategies to alleviate or reduce such effects. Funds are requested for speaker fees and the meeting is envisioned
as a series of 20-minute talks by senior investigators and 5 minute talks by graduate students and postdocs.
These speaker fees could be used by the presenters to offset some of their travel costs and allow them to attend
this conference about a complex and important topic that remains understudied.

Public health relevance
Narrative We propose to organize a one-day conference “Dosimetry and health effects of internal radionuclides” as a satellite meeting for the 17th International Congress for Radiation Research (ICRR) that will be held between August 27 - 30, 2023 in Montréal, Québec, Canada. By planning a satellite meeting we hope to attract a diverse pool of high caliber speakers and scholars in training.